Biomarker Core

BIOMARKER CORE SUMMARY
Analysis of cerebrospinal fluid (CSF), positron emission tomography (PET), magnetic resonance imaging (MRI),
and now, blood, allow operational measurement of amyloid, tau, and neurodegeneration (ATN), the major
pathophysiological changes that define Alzheimer’s disease (AD). Moreover, improved instrumentation and
advancements in analytic approaches applied to biofluidic samples and neuroimaging data both enable and
necessitate the development, refinement, and discovery of novel biomarkers. Over the past 4 years, the
Columbia ADRC has established a new, fully functional Biomarker Core that has been successful in 1) banking
and distributing fluid and neuroimaging biomarker data; 2) quantitating biofluid and neuroimaging biomarkers; 3)
initializing development and implementation of fluid biomarkers for endosomal trafficking and immune response
pathways; 3) advancing cerebrovascular, inflammatory, and artificial intelligence neuroimaging tools; 4)
providing intellectual and infrastructural support for local investigators; and 5) training the next generation of
scientists. In the next cycle, informed by the ADRC’s overall and thematic goals, the Biomarker Core proposes
to continue to interact with all components of the ADRC to build on this very strong foundation and evolve its
mission in new directions: 1) expanding focus from CSF-based to also include plasma-based fluid markers; 2)
optimizing biomarker implementation and deployment for the Center’s thematic biological pathways, with the
ultimate goal of incorporating them into clinical trials; 3) formally integrating PET neuroimaging; and 4) enhancing
our leadership in biomarker implementation among diverse populations. The Biomarker Core will continue to
collect, store, track, share, and analyze fluidic and neuroimaging biomarkers and participate in major national
and international initiatives. The success of the Biomarker Core will ultimately lead to greater insight into the
pathogenesis of ADRD, heterogeneity in disease presentation, and novel treatment avenues. The aims of the
Core are to harmonize, bank, and disseminate fluid and neuroimaging biomarkers in diverse participants;
optimize and quantitate from biofluids, amyloid and tau PET, and MRI scans according to the amyloid, tau,
neurodegeneration (ATN) framework; develop and implement biomarkers of immune response, endosomal
trafficking, and vascular pathways; lead efforts related to implementation of biomarkers in diverse populations
and provide support to investigators interested in biomarkers; and provide training to the next generation of
scientists interested in Alzheimer’s-related biomarkers.